Synthetic Multivalent Galectin Assemblies as Anti-Inflammatory Therapies

Project Summary. New anti-inflammatory therapies are needed to help the millions of Americans that are
afflicted by one or more chronic inflammatory conditions. Conventional anti-inflammatory drugs are ineffective
and limited by deleterious side-effects that result from administering drugs systemically and at high doses. Many
chronic inflammatory conditions manifest locally, not systemically. Localized delivery of natural
immunoregulatory molecules is an attractive strategy to treat chronic local inflammation. The proposed research
will develop a new anti-inflammatory therapy based on synthetic multivalent assemblies of galectin-1 (“G1”) and
galectin-3 (“G3”). G1 and G3 are natural regulators of inflammation that signal changes in immune cell behavior
via membrane glycan recognition. Despite some reported successes of wild-type G1 and G3 as anti-
inflammatory therapies, their potency is ultimately limited by their low carbohydrate-binding affinity and their
unstable active quaternary structures. To address these limitations, our approach joins G1 and G3 into synthetic
multivalent nanoassemblies. We make these nanoassemblies through recombinant fusion of G1 and G3 onto
the N- and C-termini of peptide linkers that form a-helical coiled-coils. Using this approach, we created G1/G3
Zipper, a heterotetramer with two G1 and two G3 domains (i.e., a dimer-of-dimers). G1/G3 Zipper was shown to
have significantly greater signal potency than wild-type G1 and G3 in vitro, and acts through different receptors
and different pathways than the wild-type proteins. Preliminary data demonstrate that G1/G3 Zipper can
suppress sterile inflammation induced by l-Carrageenan, whereas an engineered G1 homodimer is ineffective.
G1/G3 Zipper can also resolve imiquimod-induced psoriasis. Using a similar coiled-coil scaffold approach, we
recently demonstrated that the signaling activity of G3 increases as the number of G3 domains increases from
two to six. Informed by these data, the guiding hypothesis of the proposed research is that the anti-
inflammatory potency of G1/G3 Zipper constructs can be maximized by increasing the number of G1 and G3
domains. To test this hypothesis, Specific Aim 1 is to measure the signaling activity of G1/G3 Zipper constructs
with four or six G1 and G3 domains using various cell models of G1 and G3 signaling. Specific Aim 2 is to
evaluate the effectiveness of G1/G3 Zipper constructs to suppress local inflammation using the l-Carrageenan
and imiquimod-induced psoriasis models. We will use ELISA, bulk RNAseq, and in vivo imaging to identify the
mechanisms of action of G1/G3 Zipper. We will use in vivo imaging and histology to establish G1/G3 Zipper
pharmacokinetics. We will use humoral immunity models to assess G1/G3 Zipper safety. Completion of the
proposed studies will establish our innovative G1/G3 Zipper construct as a new class of anti-inflammatory
therapy. Harnessing the immunomodulatory activity of G1 and G3 to treat chronic local inflammation has the
potential to impact nearly all aspects of human health. Establishing valency-function relationships of G1/G3
Zipper in two inflammation models will be valuable for translation of galectin therapies.

Public health relevance
Project Narrative Harnessing the activity of natural immunoregulatory molecules to treat chronic inflammation is an attractive strategy to address the limited effectiveness and deleterious side-effects of conventional anti-inflammatory drugs. The proposed research will develop a new anti-inflammatory therapy based on synthetic multivalent nanoassemblies of galectin-1 and galectin-3, carbohydrate-binding proteins that are natural regulators of inflammation. Combining galectin-1 and galectin-3 into a synthetic nanoassembly will address the biochemical features of wild-type galectins that have limited their therapeutic effectiveness to date, thereby leading to a potent new class of anti-inflammatory therapy.